Contribution of Small Airways to Mucociliary Transport Dysfunction

PROJECT SUMMARY
The airway system is composed of asymmetric dichotomously branching tubes lined with respiratory epithelium
that form a barrier at the interface with the environment. The airways carry a simple function of conducting
oxygen rich air to the alveolar space where gas exchange with the blood occur. By doing that, pathogens and
particles enter the lungs. Mucociliary transport is a host defense mechanism that protect the lungs from
invading organisms. Defects in mucociliary transport contributes to many airway diseases such as asthma,
chronic obstructive pulmonary disease, idiopathic pulmonary fibrosis, cystic fibrosis, and primary ciliary
dyskinesia. We developed limited understanding of the mechanism of MCT in large airways by investigating
the role of submucosal gland secretions. We found that mucus strands secreted by submucosal glands are
critical to initiate movement of large particles in large airways. We also found that in CF airways, due to loss of
CFTR-mediated anion secretion, mucus strands are abnormally elastic. They fail to detach from submucosal
gland duct opening and often recoil backward while transporting on the airway surface. Small airways
constitute the majority of the surface airway of the lungs and it is suggested that may contribute to some of the
abnormalities seen in several airway diseases. The hypothesis that mucociliary defects in small airways
contribute to CF airway disease pathogenesis has largely remained untested. In addition, the characteristic
features of MCT in small airways has remained poorly understood. To understand mucociliary transport in the
small airways, we developed a positron emission based mucociliary transport assay with high spatial and
temporal resolution not achieved before. We used CF airway disease as a disease model of impaired
mucociliary transport. To realize our overarching goal of understanding the mechanism of mucociliary
transport in both small and large airways, we will test hypotheses in the following Specific Aims: Aim 1. What
is the mechanism of metachronal motion in vivo? Does disruption of mucus viscoelastic properties alter
metachronal motion? Does loss of submucosal gland mucus secretion affect metachronal motion? Is
metachronal motion impaired in CF airways? Aim 2. Is mucociliary clearance defective in CF small
airways? Does loss of CFTR cause an MCC defect? Will HEMT correct it? Will an inhaled mucolytic (TCEP)
correct it? Aim 3. Is early intervention (at birth) sufficient to prevent/delay CF airway disease? Does
HEMT revert CF airway disease back to normal in young piglets? Are mucolytics effective as a bridge therapy
until HEMT are initiated? The results are very important in understanding the mechanism of MCT and how
MCT is controlled, and ultimately identify desperately new targets for lung diseases. The results will also guide
development of newer therapeutics or combination of therapeutics.

Public health relevance
PROJECT NARRATIVE These studies will use a novel mucociliary transport assay that can measure mucus transport in the small airways at a spatial and temporal resolution not achieved before. By studying defects in CF pigs, we develop understanding of the mechanism of mucociliary transport and how it is controlled.